More than a Movement Disorder: Applying Palliative Care to Parkinson's Disease and Lewy Body Dementias

Project Summary/Abstract: Parkinson's disease (PD), Lewy Body Dementia (LBD) and related disorders are
the second most common neurodegenerative illness affecting over 1.5 million Americans and are the 14th leading
cause of death in the United States. Notably, while PD is traditionally described by motor symptoms (e.g. tremor),
more recent research demonstrates that nonmotor symptoms such as pain, depression, and dementia are
leading causes of mortality, quality of life (QOL), nursing home placement and caregiver distress. Regarding
models of care for PD and LBD, evidence suggests that care including a neurologist results in lower mortality
and nursing home placement than care solely from a primary care physician. Unfortunately, there is also
significant evidence that many of the needs most important to patients and family (e.g. pain, planning for the
future) are poorly addressed under current care models. Palliative care is an approach to caring for individuals
with serious illness that addresses multiple causes of suffering including medical symptoms, psychosocial issues
and spiritual needs. While developed for cancer patients, palliative care approaches have been successfully
applied in other chronic progressive illnesses. There is expanding interest in applying these principles to PD and
LBD. A small but growing cadre of centers now offer outpatient palliative care for PD and LBD with mounting
evidence of efficacy including a randomized trial of academic-based outpatient palliative care led by the PI. While
this work is critical to forwarding this field, further work is needed to provide models that can be widely
disseminated in the community where the majority of patients receive their care. The current proposal addresses
this gap and builds on lessons learned our original R01 grant by assessing the effectiveness and feasibility of a
novel community-based intervention that builds online learning communities around palliative care for community
neurology practices and augments care for patients and family around social support communities. We
hypothesize this intervention will improve patient QOL, caregiver burden and community provider career
satisfaction. Our Specific Aims are to: 1) Determine the a) effectiveness and b) feasibility of a novel community-
based outpatient palliative care model for PD and LBD; 2) Describe the effects of this model on patient and
caregiver costs and healthcare utilization; and 3) Identify opportunities to optimize this model by: a) describing
patient and caregiver characteristics associated with intervention benefits; and b) through direct patient,
caregiver and provider interviews. Innovations of our approach include the use of online learning communities
to implement primary palliative care with neurologists and the use of online networks to provide team-based
support and peer connections to patients and families. The research is significant because it tests a potentially
more efficient and effective model of providing palliative care to persons affected by PD and LBD, and, in
conjunction with other work conducted by our group, will provide data relevant to patients, healthcare providers,
policy makers and other stakeholders to guide future dissemination efforts in this field.

Public health relevance
Project Narrative: Parkinson's disease (PD) and Lewy Body Dementia (LBD) are a chronic neurodegenerative illnesses which affect 1-2% of people over age 65 and are associated with disability, reductions in quality of life, caregiver distress, pain, fatigue, dementia and increased mortality. While PD and LBD are typically managed using a chronic disease model focused on motor symptoms such as tremor, palliative care offers an opportunity to improve quality of life for patients with PD/LBD and their family caregivers by addressing potential causes of suffering not well met in current models of care including advance care planning, non-motor symptoms such as pain, psychosocial issues, caregiver distress and spiritual needs. This proposal will build upon work by members of this research team to conduct a pragmatic clinical trial of a novel palliative care model for PD delivered through online communities for patients, caregivers and clinicians with the specific objectives of determining whether: a) this community-based intervention is effective to improve patient quality of life or caregiver distress; and b) this approach is feasible to disseminate palliative services more widely to PD patients and their families in the communities in which they live.